AAFCO Advanced Inspector Training Seminar

Project Summary/Abstract
AAFCO Advanced Inspector Training Seminar
PAR-19-306
The Association of American Feed Control Officials (AAFCO) is a voluntary membership
association of local, state, and federal agencies charged by law to regulate the manufacture and
distribution of animal feeds.
The AAFCO Inspection & Sampling Committee ensures that the Advanced Inspector Training
Seminar (AITS) is made available to State Feed Programs to utilize for field staff training needs.
Common agenda topics are centered on Regulatory Authority, Investigative Techniques, Federal
Contract Work, Medicated Feeds and Labeling Requirements, and Emergency Response.
All personnel employed by state government agencies which perform inspections in feed facilities
are invited via email to attend the meeting, and up to sixty (60) attendees, on average, are accepted
as attendees. Historically, State Feed Programs have been limited on travel due to available
resources provided by their agency, therefore, the Association generally attempts to keep
registration costs as minimal as possible to increase the opportunity for field staff to attend.
AAFCO intends to utilize grant funding to ensure AITS provides the attendees with a robust
training on regulatory topics and professionalism subjects that have been identified as necessary
in order for animal feed inspectors to perform their duties satisfactorily.

Public health relevance
Project Narrative AAFCO Advanced Inspector Training Seminar Application PAR-19-306 Funding from this grant will allow the Association of American Feed Control Officials (AAFCO) to host an annual Advanced Inspector Training Seminar. This seminar provides informative feed regulatory presentations, interactive demonstrations such as emergency response tabletop exercise, and professional instructor led training by the Council on Licensure Enforcement and Regulation (CLEAR) in professionalism topics, including, investigative techniques, evidence collection, and report writing, that have been specifically designed for animal feed regulatory personnel.